Georgia Regulatory Cooperative Agreement to Enhance Produce Safety

Project Abstract: The development of a produce safety program will establish a uniform foundation for the regulatory oversight of Georgia commodities described in the Produce Safety Rule. The development and implementation of this program will assist federal and state programs to better direct their regulatory activities toward reducing foodborne illness hazards as related to growing, harvesting, packing, and holding of produce for human consumption. Program needs for the cooperative agreement application funding include: • Conduct assessment of the State’s produce landscape and available resources. • Establish a framework and process to develop and maintain a produce farm inventory. • Provide resources for, and invest in, program infrastructure. • Develop specific mechanisms to coordinate with local, state, and federal partners for produce safety activities. • Formulate a multi-year plan to implement a produce safety system. • Develop a performance measurement system. • Evaluate the need for new or updated produce legislative or regulatory authority. • Develop and/or provide education, outreach, and technical assistance to farming operations covered by the rule. • Develop and/or provide education, outreach, and technical assistance to jurisdictional produce safety regulators. • Design and implement a compliance program. If funded under this cooperative agreement application, Georgia will continue to strive toward full conformance with the rule as we build capacity in a produce safety program focused on public health, while working in collaboration with FDA and other stakeholders as part of an Integrated Food Safety System.

Public health relevance
Project Narrative: The Georgia Department of Agriculture’s Food Safety Division will establish and implement a successful Produce Safety Program that will enhance food safety efforts in Georgia to: a) identify potential risks more quickly; b) establish control measures to minimize the growth of pathogenic organisms; and c) increase the ability to rapidly identify foodborne illness and injury hazards. Working with the FDA and other stakeholders as part of an Integrated Food Safety System will encourage the safe production of fresh fruits and vegetables, and promote compliance with the requirements of FDA’s “Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption” rule.